Functional organization and spatial resolution of attentional feedback from frontal to visual cortex

Sensory processing is a way to understand the nervous system in action. Behavioral context
strongly affects sensory processing. For example, a brief visual stimulus is easier to detect if it
appears in a predictable spatial location. This attention to visual space strongly enhances
neural and behavioral responses to stimuli in those locations, and is thought to rely on feedback
activity from cognitive areas in frontal cortex across multiple areas of visual cortex. The detailed
neural mechanisms that allow cognitive control of multiple visual brain areas remain unknown.
Addressing this gap requires measuring neural activity from functionally and retinotopically
defined projection neurons in frontal cortex and their target neurons in visual cortex, with a
framework to relate this activity to attentional behavior. Recently, long-standing barriers for
study of visual spatial attention in mice have been overcome, permitting use of novel techniques
for functionally targeted, multi-area recordings and optogenetics to dissect how feedback
circuitry underlies effects of spatial attention. This innovative combination of techniques will 1)
define functional organization and retinotopic precision of top down feedback circuitry from
anterior cingulate cortex across primary and higher visual cortical areas, and 2) define the
functional organization and efficacy of top-down feedback projections during spatial attention.
SIGNIFICANCE. This project will meet a significant need to understand how an internal
cognitive state—attention—uses feedback to modulate the perceptual intensity of external
sensory events. Establishing a detailed blueprint for neural substrates of top-down feedback
during attention and sensory perception will provide greater understanding of cognitive flexibility,
and provide insight for conditions characterized by deficits of attention and sensory perception.
INNOVATION. The proposal provides technical innovation by functionally identifying the spatial
organization and neural substrates of retinotopic communication from higher-order to visual
brain areas during spatial attention. It provides conceptual innovation by establishing a
framework for multi-area, pathway-specific information processing and cognitive feedback that
controls the sensitivity of sensory perception.

Public health relevance
The control of sensory processing by attention is critical for behavior. We lack knowledge about the brain areas, specific neurons, and mechanisms underlying attention, partly explaining why we lack effective treatments for multiple debilitating neurological conditions characterized by disturbances of sensory processing and attention.